Characterization of a novel mycobacterial adhesin

A novel protein (HBHA)has been identified on the surface of mycobacteria including M. tuberculosis, the causative agent of TB, which appears to promote the interaction of mycobacteria with host cells. Methods have been developed for the purification of this unique protein. Evidence suggests that this protein is glycosylated and that this effects both function and immunogenicity. Research is ongoing to demonstrate that HBHA is a glycoprotein containing novel glucosylated oligosaccharides. Important binding sites and immunological epitopes have been identified and characterized. Specific regions that interculate into the bacterial membrane, that form coiled-coil initiated interactions, and that bind to proteoglycans have been identified. The role of this protein in attachment of mycobacteria to host tissues and in other bacterial interactions continues to be investigated in detail. Recently it has been shown using the Mabs developed at CBER against HBHA that a family of proteins related to HBHA might exist. Future projects will investigate the functional relationships among these family members in different species of mycobacteria.